INVESTIGATION OF PREVALENCE OF ACROMEGALY IN CARPAL TUNNEL SYNDROME

This protocol seeks to investigate the prevalence of subclinical acromegaly in patients with documented carpal tunnel syndrome. Patients with positive nerve conduction studies will be invited to participate. TSH, IGF-1, glucose and a history and physical will be obtained. Patients with positive IGF-1 will undergo OGTT. Patients with positive OGTT will have 24-hr GH sampling for definitive diagnosis of (early) acromegaly.